A Grieving Heart: Does Feeling Burdensome to Others Impact Inflammatory Outcomes During Spousal Bereavement?

Project Summary/Abstract
Grieving the death of a spouse is an extremely stressful life event. The grieving process may extend for a long
period of time, taking a physical, mental, and emotional toll on the bereaved. Bereaved individuals are at an
increased risk for morbidity and mortality, particularly within the first 6 months following the loss. Mortality rates
are heavily imbalanced by cardiovascular-related deaths, which account for 20-53% of deaths following the
loss of a spouse. However, researchers lack an understanding of the psychosocial aspects that may help
explain why some bereaved individuals die of a “broken heart”, while others do not. Self-perceived burden, a
psychosocial stressor, refers to a concern for the impact on others of one’s care needs resulting in guilt,
distress, feelings of responsibility, and diminished sense of self. Psychosocial stressors promote transcription
nuclear factor kappa B (NF-kB) activation, a prime pathway for upregulating proinflammatory cytokine
production. Inflammation is central to all stages of CVD and our preliminary data identifies inflammation as a
potential mechanism underlying CVD among the bereaved. Further, because self-perceived burden is a
psychosocial stressor, it may impact bereaved individuals’ CVD risk by promoting systemic inflammation,
thereby damaging the heart. Thus, it is important to understand when and if self-perceived burden develops
during bereavement, and how it impacts CVD risk via inflammation. In the current study, we aim to investigate
self-perceived burden, a novel psychosocial stressor, and its relationship to grief symptoms during the first
year after losing a spouse. In addition, we will longitudinally investigate the relationship between self-perceived
burden and inflammation, a marker of CVD risk. Last, we will explore which issues appear first in the time
course during the grief trajectory; specifically, we will examine whether self-perceived burden partially mediates
the relationship between earlier grief symptoms (2 months post-loss) and later inflammation (12 months post-
loss). Concurrent with an R01 project funded by NHLBI, this project will examine grief symptoms, self-
perceived burden, and inflammation among a sample of 160 bereaved individuals who recently lost their
spouse. These associations will be examined longitudinally, with data collected at 2 months, 4 months, 6
months, and 12 months after the spouse’s passing. Investigation of the relationship between self-
perceived burden and inflammation would further our understanding of who may be at risk for CVD.
Importantly, self-perceived burden is a modifiable risk factor; results may yield important information
related to the development or revision of existing clinical interventions for bereaved individuals
targeting disease prevention.

Public health relevance
Project Narrative This study is clinically relevant to public health in that it will improve our understanding of individual risk factors for CVD in bereaved adults by investigating an novel psychosocial risk factor, self-perceived burden, and its relationship to inflammation, a biological outcome central in all phases of heart disease (as well as many other diseases, more broadly). Importantly, self-perceived burden (i.e., feeling burdensome to others), is a modifiable risk factor, and thus, results may yield important information related to the development or revision of existing clinical interventions for bereaved individuals targeting disease prevention. These goals are directly in line with the National Heart, Lung, and Blood Institute’s mission to promote the prevention and treatment of heart, lung, and blood diseases and enhance the health of all individuals so that they can live longer and more fulfilling lives.